Integrative Oncogenomics of Multiple Myeloma

Project Summary – Overall Program Dana-Farber Cancer Institute
This renewal application stems from our successful renewal of our program project grant funded in 2017, which
brings together a talented group of investigators with expertise in basic biology (DFCI and Whitehead Institute
at MIT), clinical science (IFM), as well as genomic and cell signaling (DFCI and Broad Institute). During the prior
years of funding period, we have 1. Defined the role of transplant in the era of novel agents; 2 Established the
role of molecular minimal residual disease (MRD) in myeloma; 3. Identified and validated number of novel
genomic and epigenomic targets; and 4. Defined patterns of clonal evolution and mutational signatures being
utilized in MM. Our program has also developed novel targeted sequencing platform, deciphered the genomic
landscape and chronology of copy number alterations in MM, developed a pipeline to identify mutations using
RNA-seq, and developed a publicly available data analysis portal (Canevolve.org). Building on these advances,
the overall specific objectives of the program are 1) to determine whether high-dose therapy provides benefit if
MRD negative status is achieved, to define the role of sustained MRD negativity in 716 patients randomized
clinical study, and to develop novel risk model (Project 1). Clinically annotated patient samples from IFM/DFCI
2009 and the proposed clinical trial will be utilized to study genomic and epigenomic correlates (All Projects)
Project 2 will advance our understanding of the regulation of transcriptional condensates and their biochemical
environment. Project 3 will identify and validate the long non-coding RNA dependencies responsible for
continued MM cell growth and develop strategies to interrupt their activities as a novel therapeutic approach.
New targeted therapeutic agents will be translated to clinical trials to improve patient outcome. Project 4 will
define the impact of clonal complexity and identify mediators of genomic instability underlying disease
progression in MM and develop novel inhibitors targeting genomic instability. These 4 projects will be supported
by Administrative and Communication Core (1), Clinical and Tissue Core (2); Epigenomics Core (3); Genomic
Sequencing Core (4); and Biostatistical and Bioinformatics Cores (5). This unique collaborative effort will improve
our understanding of myeloma biology and define a new treatment paradigm for this presently incurable disease.

Public health relevance
Project Narrative – Overall Program Dana-Farber Cancer Institute This program will help develop minimal residual disease (MRD)-based therapeutics and will investigate whether MRD negativity should be the ultimate goal of therapy. Moreover, the oncogenomic studies will both identify genomic and epigenomic correlates of disease behavior, and clonal evolution and develop new risk stratification model as well as identify novel targets.